COBRE in Digestive and Liver Disease

Cell Models Core – Project Summary
The COBRE in Digestive & Liver Disease (CDLD) Cell Models Core will provide CDLD investigators with access
to state-of-the-art tissue culture models of digestive and liver disease. We will use genome engineering
technologies including CRIPSR-Cas9 to introduce specific genetic alterations into established cell lines and into
induced pluripotent stem cells (iPSCs). The iPSCs will be differentiated to form cells of the gastrointestinal tract
and liver that will be used for study by CDLD investigators. The Cell Models Core will also provide investigators
with primary cells isolated from transgenic and control rodents, when requested. In addition to providing CDLD
investigators cells and organoids that can be used for direct analyses, the Cell Models Core will also support
investigators by providing mentoring, training, and critical reagents to allow them to establish the procedures in
their own laboratories. Through such training opportunities, the Core will advance the technological toolbox of
CDLD investigators, increase their competitiveness for funding, and enable them to advance as experts in
digestive and liver disease research. The Core will also adopt a program of rigorous evaluation to ensure optimal
performance and continual access to new technologies as they are developed. The Cell Models Core represents
a new core research resource at the Medical University of South Carolina. Currently, this technology is only
available to digestive disease researchers. Dr. Stephen A. Duncan, who will lead the Core, is an expert in stem
cell biology and cell differentiation, and he has used genome engineering extensively to generate cells to model
liver disease. The Core also recruited the expertise of Dr. Jorge Múnera who has pioneered the generation of
colonic organoids from iPSCs. The isolation of primary cells is led by Dr. Don Rockey, who has over 30 years of
experience in isolating primary cells from rodents. The Core leadership has already worked closely with the
CDLD Research Project Leaders to generate preliminary data for their proposed projects and grant applications.
A needs assessment survey ascertained that 19 digestive disease research labs plan to use the Core in the
immediate future. The Core will therefore have a substantial impact and advance digestive disease and liver
research at MUSC.